Supporting high-intensity interval training with mindfulness for enhancing childhood executive function

Summary
Physical activity has been shown to enhance children's executive function (EF) that is fundamental for
reasoning, problem solving, and academic achievement. High-intensity interval training (HIIT), a form of
exercise consisting of short intense exercise bouts separated by recovery intervals, has gained considerable
attention due to its time-efficiency for increasing physical activity and fitness in an enjoyable and reinforcing
manner while generating chronic and acute EF benefits in children. However, none of the existing programs
utilized the recovery intervals during HIIT, which typically consist of passive and mindless breaks, despite
evidence indicating larger cognitive benefits from exercise combined with cognitively engaging activity. The
recovery intervals during HIIT provide an opportunity for mindfulness (MF), a mental exercise of self-
awareness and self-regulation that improves EF. Repeated practice on the flexible regulation of attentional
focus and bodily movement between mindful recovery and exercise bouts is theoretically sound for
maximizing long-term cognitive gains because the added MF activity provides enriched experiences and
cognitive challenges that stimulate the development of EF. HIIT and MF also have similar acute benefits to EF
yet differential impacts on neuroelectric correlates of conflict processing and updating of mental
representation. Thus, HIIT and MF may be complementary as they alter differential functional neural
underpinnings of EF. This proposal aims to test the effectiveness of a novel mindful HIIT intervention for
improving EF in 10 - 12 years old children. By using two active control interventions delivering HIIT without MF
and delivering MF without HIIT as well as a passive control intervention delivering sedentary activities without
inducing MF, we will further determine the unique effects of HIIT, MF, and their combination on children's EF.
Specifically, this proposal will conduct a 12-week school-based cluster-randomized controlled trial and a
laboratory-based acute intervention cross-over trial to investigate the long-term and short-term effects of
mindful HIIT intervention on children's EF. Our central hypothesis is that integrating MF into HIIT will generate
larger long-term and short-term positive effects on children's EF than MF or HIIT intervention along. Outcomes
consistent with our hypotheses will provide novel evidence indicating the effectiveness of chronic and acute
engagement in mindful HIIT for enhancing children's EF. The successful completion of this study will serve to
guide future randomized controlled trials testing the mechanisms and dose-response associations of the long-
term and short-term mindful HIIT interventions with behavioral and neural outcomes of childhood EF. This
research agenda will support the development of scalable and sustainable interventions that uses MF
technique to maximize the positive impacts of exercise on childhood cognitive and brain development while
counteracting many health issues centered around physical inactivity.

Public health relevance
Project Narrative Physical inactivity is well known for its negative influences on not only physical health but also cognitive functioning during child development. Understanding effective exercise-based strategies for promoting childhood physical activity as well as enhancing cognition and brain function is of great importance for maximizing children's academic potential, school performance, and overall health as they develop through the human lifespan. For the first time, our proposed study will begin empirically investigating the effectiveness of a hybrid mindfulness high-intensity interval training for generating short-term and long-term benefits to executive function in children.